GROWTH HORMONE SECRETORY ACTIVITY OF GHRH IN THE OBESE

Obesity will markedly reduce the GH secretory response to an IV bolus dose of growth hormone releasing hormone (GHRH) in obese (BMI 30 kg/m2) young men.